MOLECULAR BIOLOGY OF ANTINEUTROPHIL CYTOPLASMIC AUTOANTIBODIES

The goal of this study is to determine the etiologic factors involved in the development of small vessel vasculitis and glomerulonephritis associated with Antineutrophil Cytoplasmic Autoantibodies (ANCA).